Statistical methods for early disease prediction and treatment strategy estimation using biomarker signatures

Project Summary: Neuropsychiatric disorders pose an immense burden on patients, families, and health care systems, thus underscoring the urgent need to develop disease-modifying treatment. Research on neuropsychiatric disorders (e.g., Alzheimer's disease, Parkinson's disease) faces unique challenges, including the fact that these disorders typically have a late onset and slow progression, the diagnostic criteria are based on subjective clinical symptoms, and there is substantial disease and subject heterogeneity. In the proposed work, we aim to tackle these chal- lenges by leveraging complementary contributions from multiple biomarkers, including genome-wide polymor- phisms, whole brain neuroimaging, bioﬂuids, and comprehensive neuropsychiatric assessments. We develop sophisticated analytic tools with higher resolution and improved accuracy by accounting for biological mecha- nisms of disease, synthesizing dynamic system-wide information, and integrating multiple sources of biomarkers. These methods are applied to clinical data collected by the investigative team or available from large international consortia in order to model the earliest pathological changes of neurodegenerative disease, assess treatment responses, and inform the design of early-intervention clinical trials and the discovery of optimal personalized therapies. Speciﬁcally, in Aim 1, we develop efﬁcient methods for multi-level semiparametric transformation mod- els to estimate and test the risk of genetic variants on various types of complex phenotypes to inform genetic counseling and improve clinical trial efﬁciency. Our methods do not rely on full pedigree genotyping and provide family-speciﬁc substructure, in addition to population substructure, to better control confounding and reduce false discovery rates in genome-wide association studies. In Aim 2, we develop large-scale nonlinear dynamic sys- tems through ordinary differential equations with random inﬂections to understand early pathological changes and identify subjects with preclinical signs. Our method provides multi-domain integration of ensembles of biomarker dynamics. In Aim 3, we develop dynamic hazards models and incorporate dynamic network structures to estimate biomarker proﬁles that evolve smoothly with disease progression for earlier disease diagnosis. We account for irregularly measured biomarkers and biological network dependence among biomarkers. In Aim 4, we develop doubly robust and efﬁcient machine learning methods to identify predictive markers, estimate optimal individu- alized therapies, and identify subgroups who may receive the greatest beneﬁt from therapy, with minimal risk. In each aim, we will validate the proposed methods through extensive simulation studies and demonstrate their practical value via application to real-world clinical studies. We establish theoretical properties of the proposed methods using modern empirical process theory and statistical learning theory. Together, the state-of-the-art ana- lytic methods proposed here will substantially improve analytic accuracy, and our combined statistical and clinical expertise will ensure that our methods are translated directly back to the clinical and translational research com- munity.

Public health relevance
Project Narrative: The ultimate goal of neuropsychiatric research is to develop experimental therapeutics to delay disease on- set, slow disease progression, and provide effective treatment at each stage of disease. This proposal aims to develop new statistical approaches to integrate complementary sources of information from genomic measures, brain imaging biomarkers, and early clinical signs to characterize disease mechanism, progression, and treatment responses, and thereby inform the design of clinical trials and the discovery of optimal personalized therapies.